The Comparative Effectiveness of Single versus Dual Chamber Cardioverter Defibril

DESCRIPTION (provided by applicant): Dr. Peterson is an Assistant Professor of Medicine in the Division of Cardiology at Denver Health Medical Center and the University of Colorado Denver (UCD). She has completed a master's in public health and conducted multiple observational studies focused on quality of care and outcomes for patients with heart failure (HF). Dr. Peterson's career goal is to improve the care and outcomes of patients with heart failure by conducting comparative effectiveness research (CER) in HF. Career Development Goals and Training: The proposed K08 career development plan builds on her prior training and experiences in observational research and addresses critical areas for performing robust observational CER. The three principal developmental goals of the application are to acquire: 1) expertise in combining data sources and analytic strategies for accounting for data structure; 2) advanced training in statistical methods for causal inference in observational studies; specifically, methods for addressing confounding, including propensity scores, instrumental variables, and sensitivity analysis; and 3) advanced training in statistical methods for analyzing longitudinal data and methods for handling missing data. Accordingly, Dr. Peterson proposes focused coursework and seminars, contextual learning through the proposed research and mentorship from a team of experts. These training activities will provide experience and skills to perform CER and advance the understanding of the comparative effectiveness of therapies for patients with HF. Mentors/Environment: The primary mentor, Frederick Masoudi, MD, MSPH, is Co-PI of the AHRQ- sponsored multicenter Longitudinal Studies of ICDs (LSICDs) which will provide the data and research infrastructure for this K08. Co-mentor David Magid, MD, MPH is Co-PI of the Cardiovascular Research Network (CVRN) and is Director of Research for the Colorado Permanente Medical Group. Co-mentor Sharon-Lise Normand, PhD is a Professor of Health Care Policy (biostatistics) at Harvard Medical School and Professor in the Department of Biostatistics at the Harvard School of Public Health and an internationally recognized expert in observational CER methods. This mentorship team is highly capable of guaranteeing the completion of Dr. Peterson's proposed research and training activities. A key aspect of Dr. Peterson's research environment is the nationally recognized Colorado Cardiovascular Outcomes Research (CCOR) group. CCOR is a multi-institutional and multidisciplinary group of established cardiovascular outcomes researchers which brings together methodological and content expertise to conduct cutting-edge cardiovascular outcomes research. Another key aspect of the research environment is the Kaiser Permanente Colorado Institute for Health Research (KPCO-IHR) which will serve as the data coordination and analytic center for this proposal. The KPCO-IHR includes 116 investigators supported by research nurses, project managers, research assistants, statisticians, analysis, programmers, IT support and administrative staff. Dr. Peterson has been an Affiliate Investigator since 2005. Dr. Masoudi (primary mentor) is also an Affiliate Investigator and Dr. Magid, a Co-Mentor for this proposal, is a senior investigator at IHR. Research: With the publication of landmark clinical efficacy trials, the use of implantable cardioverter defibrillators (ICDs) for the primary prevention of sudden cardiac death in patients with HF and reduced left ventricular function has increased. However, these trials leave many questions, including optimal device selection, unanswered. More complex dual chamber devices offer theoretical benefits beyond simpler single chamber devices. However, the benefits of dual chamber devices in those without a clear indication (i.e. discretionary dual chamber devices) are not established. The research objectives of this multi-center cohort study are to identify the patient and physician factors associated with the use of discretionary dual chamber device and to compare a) peri-procedural and longitudinal complications, b) hospitalizations, c) mortality, and d) inappropriate shocks among those receiving single chamber ICDs and similar patients receiving discretionary dual chamber devices in a large, broadly representative community-based HF population. Summary: This mentored research and training proposal is also directly responsive to AHRQ's mission to improve the quality, safety efficiency and effectiveness of health care, and is specifically responsive to the comparative effectiveness priority area by proposing to 1) understand the patterns of appropriate and discretionary use of dual chamber ICDs in community-based populations and identify the demographic and clinical factors associated with the discretionary use of a dual chamber device; 2) determine the comparative safety of single and dual chamber ICDs; 3) generate critical insights on the clinical comparative effectiveness of single and dual chamber ICDs; and 4) evaluate outcomes important to stakeholders. Further, this award will facilitate Dr. Peterson's development into a nationally-recognized independent comparative effectiveness investigator in cardiovascular disease.

Public health relevance
PUBLIC HEALTH RELEVANCE: Many patients with heart failure are at high risk for sudden death due to abnormal heart rhythms. Implantable cardioverter defibrillators (ICDs) are devices designed to treat those rhythms and prevent sudden death. This study will provide information about the risks and benefits of the different types of ICD devices in real-world settings and therefore inform the best use of this invasive therapy in broad patient populations that were not studied in the randomized trials that currently guide practice. Project Narrative Many patients with heart failure are at high risk for sudden death due to abnormal heart rhythms. Implantable cardioverter defibrillators (ICDs) are devices designed to treat those rhythms and prevent sudden death. This study will provide information about the risks and benefits of the different types of ICD devices in real-world settings and therefore inform the best use of this invasive therapy in broad patient populations that were not studied in the randomized trials that currently guide practice. __SpecificAimsTextDelimiter__ Research Plan A. Specific Aims The effectiveness of implantable cardioverter defibrillator (ICD) therapy for primary prevention of sudden cardiac death (SCD) in patients with heart failure (HF) and left ventricular systolic dysfunction (LVSD) has received significant attention given the expansion in the number of patients considered eligible for this therapy.18 In the wake of landmark clinical trials,19;20 many important questions remain unanswered. One of the most important is the selection of the type of ICD to implant. While the majority of patients enrolled in the efficacy trials received single chamber ICDs (one lead in the right ventricle), patients in clinical practice often receive more complex dual chamber ICDs (leads in both the right ventricle and the right atrium).21 For a minority of patients, such as those with existing bradyarrhythmias, dual chamber devices are clearly indicated. However, for the majority of patients, use of a dual chamber ICD is "discretionary," or in other words, there is equipoise as to which device type is best. On theoretical grounds, dual chamber devices might reduce adverse outcomes, including death, hospitalization, or inappropriate device shocks. Yet, results of clinical trials comparing single and dual chamber devices in select populations have not identified benefits of dual chamber devices in terms of meaningful patient outcomes.22-25 Thus, the research objective of this proposal is to perform a rigorous comparative effectiveness evaluation of dual chamber and single chamber ICDs in a broad spectrum of patients with LVSD treated in community practice. This information will have critical implications for the sizeable population of patients at risk for SCD, clinicians, payers, and policy makers. The career development objectives of this application are to acquire expertise in 1) combining data from multiple sources, 2) advanced methods for addressing confounding, and 3) longitudinal data analysis. As such, the overarching goal of this research plan is to allow me to learn and apply rigorous methodologies in observational comparative effectiveness research. To determine the comparative effectiveness of single and dual chamber ICDs, I have assembled a mentorship/collaborator team with extensive methodological and clinical expertise. Prior studies have been unable to answer these critical questions because of the lack of an adequate data source containing information on device type, detailed baseline clinical data and longitudinal outcomes, including shocks. This project will take advantage of the unique database created through the AHRQ-sponsored Longitudinal Studies of ICDs (LSICDs) project which will contain this information and allow for a robust comparative effectiveness evaluation. We will achieve the scientific objectives of this application by pursuing the following specific aims: Specific Aim 1: In a community-based population undergoing ICD implantation for whom a single chamber device would be clinically reasonable, determine the proportion of patients who receive a dual chamber device and the patient and physician factors associated with this "discretionary" dual chamber device use. Hypothesis 1a: Patients who receive a discretionary dual chamber ICD are more likely to be younger, male, white and have fewer comorbidities than those who receive a single chamber device. Hypothesis 1b: Physicians who implant dual chamber ICDs are more likely to be younger, be certified in electrophysiology, and have completed training more recently. Specific Aims 2-4: Compare the outcomes of patients receiving discretionary dual chamber ICDs to a similar population of patients receiving single chamber ICDs among all patients and in important subgroups (older age, female gender, non-ischemic etiology of LVSD, and patients with renal dysfunction). Aim 2: Peri-procedural and long-term complications Hypothesis 2a: The risk of short and long term complications is significantly higher among patients receiving a discretionary dual chamber ICD compared with similar patients receiving a single chamber ICD. Hypothesis 2b: Clinical and demographic patient characteristics significantly modify the effect of device type on the risk of short and long term complications. Aim 3: Mortality and hospitalization (HF and all-cause) over 2 years Hypothesis 3a: The risk of mortality is not significantly different but the risk of hospitalization is greater in those who receive a discretionary dual chamber ICD compared with similar patients receiving a single chamber ICD. Hypothesis 3b: Clinical and demographic patient characteristics do not significantly modify the effect of device type on the risk of mortality, but do significantly modify the effect of device type on the risk of hospitalization. Aim 4: Inappropriate ICD shocks Hypothesis 4a: The risk of inappropriate shocks is not significantly different in those who receive a discretionary dual chamber ICD compared with similar patients receiving a single chamber ICD. Hypothesis 4b: Clinical patient characteristics (specifically atrial arrhythmias, ischemic etiology and lower LVEF) significantly modify the effect of device type on the risk of inappropriate ICD shocks.